Multi-laboratory validation of LC-MS/MS analyses of diagnostic samples including animal tissues and feeds for cereulide

2025 Romano Vet-LIRN Project Summary/Abstract
The Food and Drug Administration (FDA) Center for Veterinary Medicine (CVM) Office of
Applied Science's Veterinary Laboratory Investigation and Response Network (Vet-LIRN)
safeguards human and animal health by investigating potential animal food or drug
contamination events. During investigation of suspected microbial or chemical contamination of
animal foods/drugs, Vet-LIRN member laboratories can analyze animal diagnostic samples as
well as animal food/drug products. Animal diagnostic sample testing provides additional insight
beyond that obtained from traditional food testing laboratories. Diagnostic investigations require
detection methods that are validated for biological samples (e.g., vomitus, urine, feces, blood,
and tissues) in addition to the typical food matrices. Vet-LIRN laboratories can also provide
surge capacity testing during large-scale outbreak situations. In such instances, analytical
methods used and results reported by different laboratories must be comparable to guide sound
decision-making by regulatory officials.
The overall objective of this project is to increase the number of robustly validated analytical
methods available to Vet-LIRN member laboratories to facilitate effective, coordinated analysis
and reliable results. Specifically, we will perform multi-laboratory validation of a method to
quantify cereulide, an emetic toxin produced by Bacillus cereus, which has been implicated in
food poisoning of humans as well as animals. The method will first be validated in pet foods at
the method-originating laboratory (UKVDL) and will then be expanded to include diagnostic
samples such as feces, vomitus, serum, tissues, and other diagnostic samples. The method will
be transferred to two other Vet-LIRN member laboratories. All participating laboratories will then
complete a multi-laboratory blinded methods test (BMT) administered by a third party. Finally,
the method will be disseminated to Vet-LIRN and its member laboratories via protocols.io.
The project will improve human and animal health by increasing the number of shared, multi-
laboratory validated testing methods available to Vet-LIRN laboratories to use during outbreaks
or events of animal feed or drug contamination or adulterations.

Public health relevance
2025 Romano Vet-LIRN Project Narrative This project will help safeguard human and animal health by enhancing the ability of network laboratories to respond to outbreaks or events of poisoning due to contaminated animal feeds or drugs. This will be accomplished by further expanding the number of multi-laboratory validated analytical methods available to FDA Vet-LIRN member laboratories and facilitating the effective cooperation and seamless interactions which are necessary for large-scale emergency/surge capacity testing.